Assessing and improving the resilience of bioinformatics pipelines to data errors

Project summary
Despite significant investments in data curation, errors and other analytical artifacts abound in public biological
databases. Such errors can have an important impact on bioinformatics software, leading to analytical errors.
In certain applications, such as diagnostics or other clinical settings, such analytical errors can have important
consequences. The speed of data generation has far outpaced the speed with which biologists can
experimentally characterize molecules and organisms, or curate computer-generated annotations. Simply put,
errors cannot be eliminated in a practically-meaningful way. Furthermore, the problems induced by low data
quality are not always apparent and, thus, can be overlooked by practitioners, even if they are experts in their
own field.
This project aims to develop a better understanding of how data interact with the algorithms used in
bioinformatics research to create the potential for the analytical errors. This understanding will also lead to the
development of algorithms and strategies that are able to protect analytical results from errors in the reference
data or in the input provided to the analysis.

Public health relevance
Project narrative Data errors in public databases can have an important impact on the accuracy of bioinformatics pipelines, including those that are used in clinical diagnostics. This project will assess the vulnerability of current pipelines to errors or attacks and will develop strategies to counteract these vulnerabilities.